Well-being as a Protective Factor against Cognitive Decline and Dementia Risk

PROJECT SUMMARY
The Pathway to Independence Award will equip the candidate with the knowledge and skills to study
well-being as a key protective factor against Alzheimer’s Disease and Related Dementias (ADRD). ADRD is a
substantial and rapidly-growing public health burden, with no available disease-modifying treatments.
However, not everyone with ADRD-related neuropathology experiences symptoms of dementia. Well-being is
an understudied but important predictor of cognitive resilience to ADRD neuropathology, given that it has been
associated with ADRD risk and is amenable to intervention. The candidate will evaluate multiple well-being
predictors of resilience to ADRD pathology (Aim 1). To address questions related to direction of causality, the
candidate will examine bidirectional associations between well-being and cognitive decline in older adults with
and without ADRD (Aim 2). To increase the generalizability and replicability of findings, both research aims will
be conducted in multiple existing longitudinal datasets. To support the candidate in conducting the proposed
research, training in three areas is planned: (a) Alzheimer’s Disease and Related Dementias (ADRD), (b)
causal modeling of longitudinal observational data, and (c) Integrative Data Analysis. Training will occur under
the mentorship of renowned experts in each field (including two personality and health psychologists, an
epidemiologist, and a quantitative psychologist). During the K99 period, the candidate will receive training in
ADRD that will be applied to both aims of the proposed research and training in causal modeling techniques
that will be used in the second aim of the proposed research. During both periods of the award, the candidate
will work with the mentor team to build relationships with existing longitudinal studies and develop an
Integrative Data Analysis pipeline. The training environment at the Department of Medical Social Sciences,
Northwestern Feinberg School of Medicine will be ideal for the proposed training and research, as well as for
developing the candidate’s professional skills. Together, the award will help the candidate launch her research
career as an independent scientist with unique expertise in well-being, cognitive and physical health across the
lifespan, and longitudinal modeling.

Public health relevance
PROJECT NARRATIVE Alzheimer’s Disease and Related Dementias (ADRD) is a substantial and rapidly-growing public health burden, with no available disease-modifying treatments. Well-being is an understudied but important protective factor against ADRD risk and progression, given that it has been associated with ADRD risk and is amenable to intervention. The planned research will examine multiple types of well-being as predictors of cognitive resilience to ADRD neuropathology as well as bidirectional associations between well-being and cognitive decline.